Comparing Parent's Own Milk and Donor Milk: Differences in Viable Microbiota and Human Milk Oligosaccharide Composition and Their Influence on the Very Preterm Infant

PROJECT SUMMARY/ABSTRACT
Infants born preterm do not grow as well as their term counterparts. Poor growth during the neonatal intensive
care unit admission is associated with worse neurobehavioral outcomes. Furthermore, poor infant growth and
neurodevelopment have been linked with gut microbial changes. One protective driver of the infant gut
microbiome is the consumption of parent’s own milk (POM). POM contains its own microbiome and human milk
oligosaccharides (HMOs) unique to each parent-infant dyad. HMOs and the milk microbiome contribute to the
infant gut microbiome. However, many preterm-delivering lactating parents do not have sufficient POM, requiring
supplementation with donor human milk (DHM). DHM is pasteurized and pooled from multiple, mostly term
donors, which likely alters HMO composition and decreases live bacteria. We hypothesize that these differences
between POM and DHM likely alter the preterm infant gut microbiome and reduce the infant’s growth from birth
to 36 weeks corrected gestational age. To test this hypothesis, we will leverage ongoing sampling from a funded
cohort of parent-infant dyads born between 24 to 32 weeks gestation of age to examine milk microbiome (live
and nonviable), HMO composition, and how these relate to infant gut microbiome and infant growth.
The Specific Aims are to: 1) determine the milk microbial and HMO composition of preterm POM collected at
weeks 1, 4, and 8 postpartum compared to DHM; 2) evaluate which HMO and milk microbiota (live and nonviable)
are associated with infant gut microbial diversity and composition at weeks 1, 4, and 8 of age; and 3) evaluate
which HMO, milk microbiota, and stool microbiota are associated with anthropometric z-score changes from birth
to 36 weeks corrected gestational age. We will utilize high performance liquid chromatography for HMO analysis,
metagenomic sequencing to characterize milk and stool microbiome, and propidium monoazide to distinguish
live versus nonviable bacteria in milk. Growth will be measured by changes in weight, length, and head
circumference z-scores from birth to 36 weeks corrected gestational age.
Career Development Objectives are to 1) acquire essential knowledge in milk as a bioactive system by gaining
advanced skills in systems biology and experimental design, 2) develop core competencies in multi-omic clinical-
translational trial design and bioinformatic analysis, and 3) attain sophisticated skills in ethical and equitable
study management, scientific writing, presentation, and grant preparation. After completion of the career
development objectives and the research specific aims, the applicant will be well-positioned to obtain external
funding and conduct clinical-translational studies on nutrition and growth in vulnerable parent-infant dyads.
Study Impact: This study will identify critical differences between POM and DHM and their impact on the preterm
infant gut microbiome and growth. The data will inform potential pre-biotic and pro-biotic supplementation for
DHM in future randomized, placebo-controlled trials.

Public health relevance
PROJECT NARRATIVE Parent’s own milk (POM) has been associated with improved growth, mortality, and neurodevelopment in preterm infants compared to formula, but often lactating parents have an insufficient milk supply, requiring the donor human milk, a pasteurized, pooled milk product. The proposed study will leverage biospecimens collected for a funded cohort of parent-infant dyads born between 24 to 32 weeks’ gestation to compare POM to donor milk bioactive ingredients (human milk oligosaccharides and microbiome) at weeks 1, 4, and 8 and determine if and how these differences influence the infant gut microbiome and infant growth. This project will support the applicant’s career development objectives to become an independent investigator, obtain external funding, and conduct multi-omic clinical trials on nutrition and growth in vulnerable parent-infant dyads.